Development of phenolic small molecule inhibitors of PfATP6, a Plasmodium calcium ATPase

Project Summary / Abstract
A Sorvall LYNX 6000 superspeed centrifuge is requested to enable critical steps during protein
isolation protocols that constitute an essential part of the research plan supported by grant
1R16GM145435-01A1. At a quoted cost of $76,200, the centrifuge together with a set of three
rotors will facilitate the purification of the Plasmodium enzyme PfATP6 for activity inhibition
assays. While this type of centrifuge allows for the processing of large sample volumes at low
speeds, it also facilitates spins of smaller volumes at high speeds that create a relative
centrifugal force of 100,000 x g. The latter type of spin is essential for parts of the PI’s research
agenda and currently not possible at the PI’s institution since the chemistry department’s
Beckman TL-100 highspeed centrifuge ceased to function last year and there is no other
highspeed centrifuge on campus. Due to its age, the Beckman TL-100 model it is beyond
repair because of the unavailability of spare parts. As a result, the PI is currently taking
samples to the pharmacology department at UC Davis (20 miles away) in order to use a
highspeed centrifuge there. However, these biweekly or monthly trips to UC Davis, each one
requiring several hours of the PI’s time, are only a temporary solution and they also prohibit
student training in the use of such an instrument. Thus, the acquisition of a superspeed
centrifuge would have tremendous benefits for the project.

Public health relevance
Project Narrative The supplement will provide a high-speed centrifuge with rotors to support a project aimed at the discovery and characterization of novel compounds that hold promise as novel antimalarial agents. The requested instrument is essential for the planned research and will replace an older model that broke down recently.